Use of a GLP-1 Agonist to Treat Opioid Use Disorder in Rats and Man

Project Summary. According to the Centers for Disease Control and Prevention, there were 70,237 drug
overdose deaths reported in the United States in 2017, more than 130 per day, with 67.8% involving opioids
[1]. While medications are available to treat the disease (e.g., methadone, suboxone, and extended release
naltrexone), relapse rates remain alarmingly high [2-4]. Clearly, new approaches are needed. To this end, we
recognize that addiction involves not only hijacking of the reward pathway, but also of the need pathway [5]. As
such, we posited that heroin seeking and taking should be reduced by peripheral stimulation of the glucagon-
like peptide-1 receptor (GLP-1R) ‘satiety’ pathway. In support, activation of the GLP-1R pathway has been
shown to inhibit not only ingestion of palatable sweets, water when thirsty, and salt when sodium deprived, but
also responding for alcohol, nicotine, and cocaine in rats and mice [6-12]. Here, we show for the first time that
pretreatment with a GLP-1R agonist also reduces heroin taking, seeking, and drug-induced reinstatement in
rats. The objective of this application is to test whether treatment with a GLP-1R agonist can reduce relapse in
humans with an opioid use disorder (OUD). One advantage of using GLP-1R agonists is that various
formulations already are approved for treatment of obesity and type 2 diabetes [13, 14]. UG3 Phase Aim G1
will conduct a randomized, double blind, placebo-controlled pilot study to determine whether once daily
treatment with the shorter acting GLP-1R agonist, liraglutide, can safely and effectively reduce craving and
brain responses to drug cues among patients in residential treatment for an OUD. UG3 Phase Aim G2 will use
well established animal models to test the efficacy and safety of a more risky, longer-acting, but more
efficacious, GLP-1R agonist, semaglutide, on heroin seeking and cue/drug/stress-induced reinstatement.
Milestones: (1) Demonstrate safety and efficacy liraglutide at approved doses to reduce craving and brain
responses to drug cues among patients in residential treatment for OUD who also are receiving counseling
only (CO) or counseling+buprenorphine/naltrexone (BUP/NA); (2) Verify that semaglutide is safe and effective
in reducing cue/drug/stress-induced heroin seeking in an animal model. If these milestones are met, UH3
Phase Aim H1 will conduct a two-arm, pseudo-randomized, placebo controlled multi-site clinical trial in
outpatients with an OUD to test whether treatment with semaglutide vs. placebo will reduce relapse out to 180
days in patients treated with CO and counseling+BUP/NA. UH3 Phase Aim H2 will use animal models to
further probe the efficacy and usefulness of semaglutide to prevent initiation of heroin self-administration, to
reduce ongoing heroin self-administration, or to serve as a non-opioid “bridge to care”, for example. If our
hypotheses are supported, we will show that treatment with GLP-1R agonists can safely and effectively reduce
opioid craving, seeking, and relapse in rats and humans, providing a second indication for full multi-site, Phase
III clinical trials, and we will lay the preclinical and clinical groundwork for approval from the FDA.

Public health relevance
Narrative Statement. Opioid overdose continues to take the lives of tens of thousands of Americans annually. Here, we will test whether treatment with a promising glucagon-like peptide-1R (GLP-1R) agonist, already approved for the treatment of obesity and type 2 diabetes mellitus in humans, can safely and effectively reduce cue/drug/stress-induced reinstatement of heroin seeking behavior in an animal model and, importantly, craving, risk of relapse, and relapse in humans undergoing treatment for an opioid use disorder. If milestones are met, the data will provide a second indication for further multisite clinical trials.